Validation of non-electrophile Nrf2 activators for WTC relevant pulmonary indications

The current proposal is designed to lay the foundation for a medicinal-chemistry driven translational project to optimize a non-electrophilic Nrf2 activator. Nrf2 is the body's master regulator for defense against oxidative stress. Nrf2 is a transcription factor and is activated in oxidative environments through inhibition of the ubiquitin ligase Keap1. In oxidative environments, oxidation of redox-active cysteines on the surface of Keap1 leads to its inactivation. This increases Nrf2 levels and up-regulates the expression of Nrf2 target genes, which represent an array of proteins designed to mitigate oxidative stress. Traditionally Nrf2 activators were weak oxidants that covalently react with the intended Keap1 cysteine but also modify numerous unintended proteins. Nrf2 activators have had narrow therapeutic windows due to toxicity resulting from their non-specific reactivity. This proposal is unique in the use of non-electrophilic Nrf2 activators discovered in our lab that disrupt Nrf2 ubiquitination without covalent modification through disruption of protein-protein interactions. We have seen excellent induction of Nrf2 target genes in vivo without signs of toxicity at the tested doses. Nrf2 is an attractive target for pulmonary fibrotic diseases. Disease models have demonstrated that oxidative stress plays a key role in the development of pulmonary fibrosis and modulation of Nrf2 signaling chemically and genetically impact disease progression. World Trade Center responders have two to five times elevated risk of pulmonary fibrosis, which increases with intensity and duration of exposure to WTC dust/debris and work on the debris pile. WTC responders are younger than the average pulmonary fibrosis patient, and improved treatments that slow or stop the progression of pulmonary fibrosis and increase life span are needed. WTC-relevant pulmonary models will be used to test the lead Nrf2 activator as a stand- alone treatment and in concert with a recently approved drug for idiopathic pulmonary fibrosis. There is no cure for pulmonary fibrosis, and while two new therapies have shown a benefit in slowing the decline of forced vital capacity (the volume of air that can be forcibly exhaled after taking a deep breath), they have not demonstrated increased lifespan. Improved therapies working independently or providing additive benefit when given together with current medications would have a significant impact on human health.

Public health relevance
The incidence of pulmonary fibrosis in World Trade Center responders is significantly increased and tracks with duration of exposure. Current therapy options are limited and have not been demonstrated to increase life expectancy. We plan to test an exciting lead compound in World Trade Center relevant models of pulmonary fibrosis.